Class Switch Recombination in B Lymphocytes

The proposed research continues to focus on the mechanisms that regulate development of the high affinity
antibody responses which are essential to vaccine development. There are several critical aspects to these
responses that are entirely B cell specific. First, clonal expansion which occurs in special microanatomic
structures called germinal centers (GC). Second, diversification of antibody genes by somatic mutation (SHM)
and class switch recombination (CSR), both of which are initiated by activation induced cytidine deaminase
(AID). Although AID prefers antibody genes, it is not entirely lg specific and off target activity is the primary
cause of B cell cancers in humans. The third B cell specific aspect of high affinity antibody development is
selection for clones of B cells that express high affinity receptors. In the first 4 years of the funding period, as
part of the original Aims 1 and 2, we examined the mechanisms by which AID targets lg genes and misstargets
cancer genes in the germinal center. Moreover, we documented the cellular and cell biological regulation of B
cell clonal expansion in the germinal center. We have initiated research on Aim 3 and have made significant
progress in understanding how Rif-1 mediates its effects on CSR by studying its interaction partner ZYMD8
which has an important role in AID targeting.

Public health relevance
High affinity, AID dependent, antibody responses are essential to nearly all vaccines. The proposed research aims to develop an understanding of how antibodies are modified and repaired after AID mediated DNA damage with the long-term goal of being able to impact vaccine development and prevent the off target effects of AID that are associated with malignancy.